The Role of Creb5 in Maintaining Synovial Joint Homeostasis

Project Summary/Abstract.
The broad, long-term goal of this project is to develop a comprehensive understanding of the regulatory network
that regulates the differentiation and maintenance of articular cartilage, which plays a central role in maintaining
the low-friction environment of the joint space. Indeed, a hallmark of cells comprising the articular cartilage is
their expression of proteoglycans, such as the protein lubricin, encoded by the Prg4 gene, that lubricates the
joint and protects against the development of arthritis. Prg4 is specifically expressed in the superficial-most
layer of the articular cartilage. Findings by both the Lassar lab and others have established that Prg4-expressing
cells in the superficial zone of articular cartilage (in embryonic and early post-natal mice) serve as a stem cell
population for all deeper regions of the articular cartilage in the adult. Furthermore, in both humans and mice
lacking Prg4 (which encodes lubricin), the surface of the articular cartilage becomes damaged and precocious
joint failure occurs. Notably, decreased levels of lubricin have been observed following surgically induced
osteoarthritis in sheep, and in synovial fluid from patients with either osteoarthritis or rheumatoid arthritis.
Furthermore, a decrease in lubricin expression during aging, correlates with increasing sensitivity of aged knees
to cartilage degradation. Thus, a key objective of the Lassar lab has been to identify tissue-specific transcription
factors that regulate the expression of both Prg4 and other genes that are specifically expressed in the superficial
zone of the articular cartilage. Recent findings in the Lassar lab indicate that the transcription factor Creb5 is
uniquely expressed in superficial zone articular chondrocytes (as opposed to both deeper zone articular
chondrocytes and growth plate chondrocytes) and is a crucial regulator of Prg4 expression. Most notably, ectopic
expression of Creb5 in deep zone bovine articular chondrocytes (which do not expression Prg4) enabled TGF-b2
and EGFR signals to induce Prg4 expression in these cells, to a level equal to that expressed by superficial zone
articular chondrocytes. These findings suggest that Creb5 establishes a competent state in chondrocytes to
express Prg4 in response to these signaling pathways. In addition, the Lassar lab has found that mice engineered
to lack functional Creb5 fail to form many synovial joints. Taken together, these findings indicate that Creb5
plays a critical role in both the formation of synovial joints and is a both a novel and crucial regulator of
Prg4/lubricin expression in articular chondrocytes. This project will determine the role of Creb5 in maintaining
the health of all tissues in the mature synovial joint; will determine whether expression of Creb5 in either
articular chondrocytes or synovial fibroblasts is attenuated during aging or during osteoarthritis; and finally will
determine whether sustained expression of exogenous Creb5 in the synovial joint can boost lubricin expression
and block degradation of this tissue either during aging or in a murine model for post-traumatic osteoarthritis.

Public health relevance
Project Narrative The broad, long-term goal of this project is to develop a comprehensive understanding of the regulatory network that regulates the differentiation and maintenance of articular cartilage, which plays a central role in maintaining the low-friction environment of the joint space. A hallmark of cells comprising the articular cartilage is their expression of proteoglycans, such as the protein lubricin, encoded by the Prg4 gene, that lubricates the joint and protects against the development of arthritis. Successful completion of this proposal will provide fundamental new insight into the events that maintain lubricin expression in articular cartilage, with additional implications for regeneration of articular cartilage in degenerative joint diseases including osteoarthritis (OA) or rheumatoid arthritis (RA).